Molecular and Mechanical Investigations to Define Collagen and Elastic Fiber Homeostasis in Cervical Remodeling During a Term and Preterm Pregnancy

Abstract
The remodeling of the cervix to prepare for birth begins early in pregnancy and is orchestrated by a precisely
timed change in the structure and mechanical function of the cervical extracellular matrix (ECM). Understanding
the molecular pathways that alter the ECM in pregnancy while maintaining a synthesis and degradation
equilibrium is necessary to discern cervical function and how it mechanically protects the fetus. More importantly,
it is critical to determine when and how these cervical ECM synthesis and degradation processes are perturbed,
which compromise cervical mechanical function and creates a risk for preterm birth. Our groups prior work
provides evidence 1) of rapid collagen turnover rates in both nonpregnant and pregnant cervix 2) dysfunctional
cervical extracellular matrix leads to disrupted cervical biomechanical function in novel mouse models 3) cervical
mechanical properties evolve in distinct stages in concert with shifts in ECM structure and 4) mouse models of
cervical dysfunction are a useful tool to evaluate cervical mechanics. Building on these findings, we aim to better
define molecular pathways of collagen degradation and elastic fiber elastogenesis that ensure ECM homeostasis
in physiologic remodeling. Secondly, we aim to understand the complexity of mechanical parameters derived
from collagen and elastic fibers at multiple length scales. Collectively, the proposed studies, based on compelling
preliminary data, can expand our understanding of basic mechanisms in cervical biology and mechanobiology
and expand the possibilities for clinical intervention in PTB.

Public health relevance
Narrative Understanding the molecular processes by which the cervix undergoes a remarkable remodeling through pregnancy from closed and rigid to compliant for safe delivery is critical for defining causes of premature remodeling in preterm birth and for the identification of biomarkers to assess risk of prematurity as well as therapies for prevention. The purpose of this study is to understand how synthesis, assembly, and degradation of cervical collagen and elastic fibers is altered during pregnancy to impact mechanical function and regulated by steroid hormones in clinically relevant animal models. The knowledge gained from these studies has the potential to (1) identify clinically-relevant pathways that can be targeted for prevention of preterm birth and (2) identify new mechanical parameters to diagnose cervical dysfunction associated with preterm birth.